Understanding the contribution of the mediodorsal thalamus in gustatory processing

PROJECT SUMMARY
Recent studies on the gustatory portion of the insular cortex (gustatory cortex, GC) have demonstrated its role
in integrating sensory, affective, and cognitive signals associated with the experience of food. Indeed, GC
neurons do not just encode the chemosensory features of gustatory stimuli but can also process hedonic value
(i.e. liking or disliking) and information on multisensory stimuli anticipating taste. Understanding how GC
performs the complex integration of chemosensory, affective, and anticipatory information is one of the major
efforts in the field.
It is generally believed that GC achieves this level of integration by processing inputs from sensory and limbic
areas including the gustatory thalamus (VPMpc), the basolateral amygdala (BLA), and the mediodorsal thalamic
nuclei (MD). While the functions of VPMpc and BLA have been studied, very little is known regarding the
contribution of MD in taste. Using mice as a model system, the proposed research will rely on multiple
experimental approaches to test the general hypothesis that the MD conveys taste quality, reward-related, and
associative signals that contribute to processes in the GC that can impact taste-related behaviors. Specific Aim
1 will use electrophysiological recordings and behavioral training to characterize the taste and taste-predicting
cues response profile in the MD. Specific Aim 2 will combine neural recordings, behavioral training and
chemogenetic manipulation to unveil the effect of MD inputs on GC response profiles pertaining to taste quality
and taste-predicting anticipatory cues. Finally, the experiment in Specific Aim 3 will rely on a behavioral task and
chemogenetic manipulation to determine the role of the MD-GC connection in helping to establish incentive
values of neutral auditory cues in the acquisition of cue-taste associations.
Altogether, the results obtained from these experiments will provide a comprehensive system-level
investigation on the role of MD in taste processing. If successful, this work will lead the way for the MD thalamus
as a potential crucial brain region involved in the integration and communication of behaviorally relevant
chemosensory information.

Public health relevance
PROJECT NARRATIVE Based on its neuroanatomical connection, the mediodorsal thalamus (MD) could be a key taste-processing brain area; however, we have surprisingly very little knowledge on its role in gustation. Here we use electrophysiological recordings and chemogenetic manipulations in behaving rodents to uncover the contribution of MD neurons in integrating taste-related information, modulating neural activity in gustatory cortex (GC), and shaping gustatory behaviors. By providing a comprehensive system-level investigation on the role of MD in taste, these results will help us better understand how the brain controls feeding behavior as well as the circuits involved in dysfunctional eating.